Bacterial cell wall remodeling, innate immunity, and pathogenesis

Project Summary
Infections caused by Staphylococcus aureus remain one of the most significant burdens to human health with
~750,000 associated deaths worldwide reported in 2019; a third of which were directly attributed to antimicrobial
resistance. Many therapeutics that target peptidoglycan synthesis are ineffective against S. aureus on account
of these resistance adaptations. In the absence of effective antimicrobials, the host depends on rapid detection
by the immune system to provide protection against S. aureus infection. However, this response must be
calibrated to balance the beneficial outcomes of inflammation on infection clearance with the pathological
consequences of excessive inflammation that include tissue damage and compromised infection resolution. A
portion of the host inflammatory response against S. aureus is incited by peptidoglycan, yet we lack a molecular
understanding of how peptidoglycan recognition shapes the balance between immune-mediated clearance of
microbes and inflammatory pathology. One of the primary cytokines required for the host inflammatory response
to S. aureus is IL-1β, yet we also do not know how S. aureus calibrates IL-1β responses to persist during
infection. We recently tested if S. aureus peptidoglycan modifying enzymes known as glucosaminidases shape
innate immune responses to S. aureus and identified the staphylococcal N-acetyl glucosaminidase B, SagB, as
a central mediator IL-1β maturation by immune cells. SagB appears to promote IL-1β production from innate
cells by processing peptidoglycan to shortened lengths that are normally required to establish cell wall rigidity
and bacterial cell size. SagB-mediated IL-1β production was independent of canonical pattern recognition
receptors that recognize Gram positive peptidoglycan as well as the NLRP3 inflammasome. Instead, infection of
macrophages with a ∆sagB mutant led to reduced caspase-1/11-independent cleavage of pro-IL-1β and its
accumulation in the macrophage cytosol. Furthermore, SagB was required for virulence in systemic infection
and promoted IL-1β production and inflammatory pathology in a skin and soft tissue infection model. Our
supporting data suggests that SagB-mediated processing of peptidoglycan can offset the balance between
beneficial and pathological inflammation through a previously undescribed mechanism of IL-1β maturation. We
hypothesize that SagB processes peptidoglycan to a biologically active short glycan required for host induction
of IL-1β. Furthermore, we hypothesize SagB-mediated IL-1β production by immune cells occurs via a non-
canonical pathway that drives maturation and possibly release and promotes inflammatory pathology and
infection in vivo. Aim 1 will determine how and where SagB-modified peptidoglycan products are recognized by
innate immune cells and determine how peptidoglycan cross-linking and glycan length drive recognition. Aim 2
will investigate the mechanism of SagB-dependent IL-1β maturation and release. Aim 3 will establish how SagB
promotes infection during local and disseminated infection and will ascertain how peptidoglycan synthesis
enzymes or cell wall targeting antibiotics interface with SagB to promote infection.

Public health relevance
Project Narrative Bacterial peptidoglycan is a constituent of the cell envelope that subverts host immune defenses, establishes cell shape and division properties, and provides protection against environmental stressors. This proposal will investigate how peptidoglycan processing by Staphylococcus aureus promotes recognition by the host immune system to induce inflammatory pathology and promote infection. These studies will provide unprecedented mechanistic insight into the diverse ways bacterial cell wall glycans activate the immune system and will expand our understanding of host-pathogen interactions for staphylococci with potential extensions to other Gram- positive pathogens.